In Vivo Incorporation of Unnatural Amino Acids

Project Summary/Abstract
Our laboratory, and now many others, have added well over 100 noncanonical amino acids
(ncAAs) to the genetic codes of single and multi-cellular organisms [1, 2]. These amino acids
include spectroscopic probes, metal ion chelators, post-translationally modified amino acids and
stable analogues thereof, amino acids with bio-orthogonal chemical reactivity,
photocrosslinkers, and a host of other novel functions. Moreover, we have distributed this
technology to hundreds of laboratories throughout the world to probe protein structure and
function both inside and outside the cell, to engineer proteins with enhanced catalytic, physical
and biological properties, and to create novel biotherapeutics. Here we propose to further
expand our ability to manipulate the genetic code and apply this approach to important
problems in biomedical research including exploring the function of short open reading frame
encoded peptides, evolving proteins with enhanced properties, and genetically encoding ncAAs
in hematopoietic stem cells and lineages derived therefrom in mice.

Public health relevance
Project Narrative The ability to genetically encode unnatural amino acids beyond the common twenty significantly enhances our ability to manipulate protein structure. The result of this project will be new tools to study protein function in vitro and in vivo and new strategies to generate novel proteins with novel chemical or biological properties.